SLEEP DISTURBANCES IN YOUNG CHILDREN OF MOTHERS WITH AN AFFECTIVE DISORDER

The incidence and stability over time of sleep disturbance, based on mothers' reports, are examined in children whose mothers have a diagnosis of bipolar depression, children whose mothers have a diagnosis of unipolar depression, and well mothers. Mothers' reports were obtained twice on two of their children: (a) on the younger children when they were between 2 and 3 1/2 years old and again when they were between 5 and 6 1/2 years old: and (b) on the older children when they were between 5 and 8 years old and again when they were between 8 and 11 years old. In addition, sleep problems in these children are examined in relation to incidence of depression in parents; i.e., in children who have two depressed parents, children who have one depressed parent, and children who have no depressed parents.